Effect of Corneal Preservation Time on Long-Term Graft Success-Coordinating Ctr.

The Coordinating Center at CWRU and University Hospitals Eye Institute has constituted itself for the purpose of this proposal into two Modules (the Clinical Site Coordination Module and the Cornea Image Analysis Reading Center Module) to oversee its activities and coordinate its activities with the DMAC at the Jaeb Center for Health Research.